Training in Complex Systems and Data Science Approaches Applied to the Neurobiology of Drug Use

The purpose of this program is to train pre- and post-doctoral scholars in the application of complex systems
and data science approaches to the neurobiology of substance abuse, with the dual strategies of: (1) training
candidates with expertise in data science, applied mathematics, computer science, and complex systems to
apply their skills to the neuroscience of addiction; and (2) training candidates pursuing addiction research from
neuroscience, psychiatry, psychology and genetics in the theory and application of Big Data methods,
including network analysis, machine learning algorithms, and Bayesian statistical models. Trainees will be
paired across disciplines, and academic stages, for research collaboration and reciprocal tutoring to facilitate
the development of proficiency in each trainee's new field. Each trainee will also be dual mentored, their
secondary mentor being their partner's primary. Over its five-year duration, the program will provide three
years of funding for each of five pairs of pre- and post-doctoral researchers, with an initial cohort of four (two
pairs), and additional pairs entering in each of the middle three years. The core curriculum will incorporate: (1)
the established complex systems and data science graduate certificate at the University of Vermont; (2) course
work in neuroscience, psychology and addiction, including classes focused on developing human subjects
research skills; as well as (3) specialized courses designed to directly and effectively bridge the gap between
the core disciplines. Trainees will also attend a biweekly journal club and monthly seminar, led by senior
participants in the program, to further support the acquisition of multidisciplinary research skills.
The overarching aim of the program is to produce researchers poised to apply state-of-the-art analytic tools to
understand the neurobiology of drug abuse. The focus will be characterizing the neural substrates of addiction
and other comorbid psychopathologies, always with an eye toward clinical application. Recent increases in the
quantity and quality of large-sample, multi-modal datasets that address the neural, genetic and environmental
substrates of addiction make this a propitious time for such a training program. Researchers at UVM are ideally
suited to provide this training as there exist close links between addiction research, cognitive neuroscience,
complex systems and data science, and the mentoring faculty have access to exceptional datasets that are
ideal for interrogation with Big Data methods. Armed with coherent domain knowledge and practiced with
advanced methods for complex systems, trainees will develop analysis pipelines that: (1) incorporate
sophisticated aggregation of longitudinal and multi-modal datasets, including various neuroimaging modalities,
genetic information, survey and clinical data; (2) harness the power of supercomputing and modern machine
learning algorithms to step beyond linear and univariate effects; and (3) address questions of immediate
clinical importance to substance abuse that can inform the determination of risk factors, treatment and
intervention strategy, and policy decisions.

Public health relevance
The overarching aim of this training program is to produce substance abuse researchers well versed in the theory and application of state-of-the-art analytic tools for complex systems in the context of cognitive neuroscience broadly defined. The research focus is on characterizing the neural substrates of addiction, with natural extensions to the study of other psychopathologies, and all work undertaken will maintain an eye toward clinical application. Research results, methods and analysis pipelines developed by trainees and their mentors will be made publically available, and may inform the determination of risk factors, treatment and intervention strategy, and policy decisions made by public health professionals.!